Improving emergency psychiatric care through machine learning, causal inference, and psychometrics

Background: The United States is experiencing a crisis in mental health care, in which long-term shifts
towards the emergency department (ED) for psychiatric treatment have been exacerbated by the COVID-19
pandemic – reduced inpatient hospitalization capacity, delayed outpatient appointments, extended ED
boarding, and staffing shortages, combined with substantial growth in demand for mental health services (due
in part to pandemic-related increases in stress, depression, social isolation, and anxiety, and with differential
impacts on vulnerable populations). Data-driven approaches have not been widely applied to understand
mechanisms and predictors of ED utilization for psychiatric patients, or to optimize clinical decision-making to
improve patient outcomes. Research: In this study, I will conduct secondary data analysis of 141,431 ED visits
for psychiatric care in a large regional health system from 2017-2023, extracting and preparing over 5,000
patient characteristics from the electronic health record (diagnoses, labs, medications, procedures, visits, and
notes). Aim 1: I will create a transdiagnostic subtyping system, using latent class analysis, hierarchical density-
based clustering, and neural network autoencoders, to reliably categorize and track major trends in patient
populations receiving emergency psychiatric care. Aim 2: I will develop a suite of ensemble machine learning
models to predict ED length of stay, ED boarding duration, short-term ED re-admission, transfer to inpatient
hospitalization, and post-discharge adverse events (suicide attempt, overdose, or psychotic episode). Aim 3: I
will estimate a precision treatment rule, using targeted causal inference and ensemble machine learning, to
capture heterogeneous treatment effects for primary ED disposition decisions (inpatient hospitalization, partial
hospitalization / intensive outpatient program, or outpatient monitoring) on adverse psychiatric events.
Candidate's Career Development, Goals, and Environment: This proposal's research aims and the
candidate's career development will be supported by the extensive resources available at Massachusetts
General Hospital (MGH) and Harvard Medical School, as well as formal training, coursework, and mentorship
in (T1) mental disorders and psychopathology, (T2) precision treatment optimization, (T3) hybrid pragmatic
effectiveness trials, and (T4) professional development in preparation for a future R01 submission. The
mentorship team includes Primary Mentor Dr. Jordan Smoller, a leading expert in precision psychiatry; Co-
Mentors Dr. Matthew Nock, a leader in mental disorders and suicide prevention; Dr. Susan Murphy, a leader in
precision treatment optimization; and Dr. Stephen Bartels, a leader in implementation science and hybrid
pragmatic trials; and Consultants Dr. Suzanne Bird, expert in emergency psychiatry and director of MGH Acute
Psychiatry Services; Dr. Edwin Boudreaux, expert in hybrid pragmatic trials in emergency psychiatry; and Dr.
Soroush Saghafian, expert in reinforcement learning to optimize hospital decision-making. This award will
enable the candidate to develop an independent, rigorous research program in computational mental health.

Public health relevance
Project Narrative The United States is experiencing a crisis in mental health care, with overcrowding and delayed mental health care in emergency departments (EDs) exacerbated by the COVID-19 pandemic and with differential impacts on vulnerable populations. In this study, I will analyze ED visits for psychiatric care in a large regional health system, developing: 1) a transdiagnostic subtyping system to track trends in patient mixes, 2) machine learning models to predict ED utilization and post-discharge adverse events (suicide attempt, overdose, or psychotic episode), 3) a precision treatment rule for primary ED disposition decisions on adverse psychiatric events. By combining a large observational database with data science methods, this project will provide unique insights into modifiable risk and resilience factors, opportunities for personalized treatment approaches, and will inform the effective delivery of mental health services, contributing to mental health equity for vulnerable populations.